Improving rigor and reproducibility in adaptive optics ophthalmoscopy

PROJECT SUMMARY
Adaptive optics (AO) ophthalmoscopy allows non-invasive visualization of microscopic retinal structures by
correcting the optical blur that is unique to each eye, potentially enabling improving the understanding and
management of eye disease. Lack of standardization, however, has hindered the adoption of this technology in
the multi-center studies that are the gold standard for testing novel treatments. The overarching goal of this
project is to improve rigor and reproducibility in AO ophthalmoscopy, in order to materialize its potential through
three specific aims:
Aim 1. To develop, build and distribute calibrated model eyes that allow precise compensation of image
distortions and scaling errors caused by the optics of AO ophthalmoscopes. These model eyes will be designed
to be reproducible by others and have similar optical properties to those of an average human eye.
Aim 2. To develop imaging protocols and algorithms that use whole-eye optical biometry to allow precise
compensation of image distortions and scaling errors caused by the unique optics of each eye.
Aim 3. To collect an open normative dataset of photoreceptor mosaic images in subjects free of eye disease,
and to use it to test two hypotheses. First, that rod photoreceptors are lost to aging at a rate of ~1% per year in
the central portion of the retina that is affected in various leading blinding conditions, such as age-related macular
degeneration. Second, that rod photoreceptor spacing increases with cell loss, offsetting the decline in density,
and thus can be used for detecting early signs of disease. The image scaling and distortion correction methods
from Aims 1 & 2 will improve our ability to perform these tests.
The deliverables of this project will incorporate feedback and testing by the AO retinal imaging community.
At this project’s conclusion, users of AO ophthalmoscopes will receive software and calibrated model eyes for
precise image scaling and correction distortion, as well as the most anatomically truthful and accurately scaled
photoreceptor normative dataset. The proposed practices will facilitate the development of retinal imaging
biomarkers that improve early diagnosis and management of eye disease, as well as testing of novel therapies.

Public health relevance
PROJECT NARRATIVE Adaptive optics (AO) ophthalmoscopy reveals the retina at the microscopic scale non-invasively by compensating the optical blur that is unique to each eye. The proposed scaling and correction of image distortion in AO retinal images, together with the data gathered from controls free of eye disease, will improve our ability to study and manage eye disease. The deliverables of this project will be shared across the research community to promote the standardization that is necessary for the multi-center studies that are the cornerstone of evidence- based medicine.